Juvenile hormone transporters in disease vector physiology

PROJECT SUMMARY/ABSTRACT
Development and reproduction of insects, including human disease vectors such as mosquitoes, are
mainly controlled by two lipophilic hormones: ecdysone and juvenile hormone (JH). Although these hormones
need to enter their target cells to exert their biological effects, almost nothing is known regarding molecular
mechanisms that regulate hormone transport across cellular membranes. This is due to the prevailing dogma
in endocrinology that lipophilic hormones enter and exit cells by simple diffusion across lipid bilayers. However,
despite this dominant assumption, the simple diffusion model of lipophilic hormone transport is not supported
by any conclusive evidence in any organism. Indeed, recent studies now suggest that some lipophilic
hormones, including the insect steroid hormone ecdysone, require membrane transporter proteins to travel
across plasma membranes. The overall objective of this project is to identify and characterize membrane
transporters required for JH trafficking across cellular membranes, and to thereby challenge the conventional
paradigm that lipophilic hormones freely enter and exit cells by simple diffusion. The approach will combine in
vitro and in vivo approaches to characterize JH Transporter (JHT), which was discovered in preliminary studies
using the fruit fly model system. In Aim 1, functions of the JHT ortholog in the yellow fever mosquito Aedes
aegypti, the primary vector for Zika, yellow fever, chikungunya, and dengue viruses, will be thoroughly
investigated in vitro using an arsenal of molecular genetic tools. In Aim 2, JHT functions will be further studied
genetically in Aedes. As JH controls both growth and reproduction in Aedes and other mosquitoes,
characterization of Aedes JHT is expected to aid our effort to combat these deadliest disease vectors for
humans. Indeed, in Aim 3, in vitro chemical screening will be conducted to identify compounds that can inhibit
functions of Aedes JHT, and their effects will be tested in vivo. The significance of this project is therefore not
just to overturn the long-standing dogma in endocrinology, but also to provide a critical proof of concept as well
as seed compounds for developing novel pharmacological tools to control mosquitoes and other deadly
disease vector insects.

Public health relevance
PROJECT NARRATIVE Juvenile hormone is a lipophilic terpenoid hormone that controls development and reproduction in all insects, including human disease vectors such as mosquitoes. Although textbooks state that lipophilic hormones simply diffuse across cellular membranes, this simple diffusion model has never been established for any hormone in any organism. This project challenges the prevailing dogma in endocrinology and characterizes membrane transporters for juvenile hormone in mosquitoes, aiming to develop novel tools for controlling disease vector insects.